Structure and Function of the Nuclear Pore Complex by Cryogenic-EM

Structure and Function of the Nuclear Pore Complex by Cryogenic-EM
Abstract
The nucleus is compartmentalized by double membranes of the Nuclear Envelope (NE) and
macromolecules must cross this barrier during cell growth and differentiation. The Nuclear Pore Complex
(NPC) forms a conduit for the bidirectional transport of proteins and RNA-protein complexes between the
cytoplasm and nuclear interior. Regulated access to this gateway is used to control gene expression.
Together, four co-axial rings form a cylindrical scaffold comprised of Nucleoporins (Nups). This scaffold
anchors Nups with flexible FG-repeats (FXFG/GLFG) that project into the central channel to form a barrier
in the constricted ground state, while FG-repeats in the dilated NPC provide binding sites for the transport
of karyopherin/importin cargo complexes. A deeper understanding of this mechano-sensitive translocation
channel requires a detailed knowledge of the core scaffold and the enigmatic central transporter.
In a series of recent papers, we determined Nup domain models for isolated and in situ yeast NPCs
with cryogenic electron tomography in their ground state and dilated conformations, respectively. We
extended this work with cryogenic-EM and single particle methods to study the isolated NPC and provide a
composite, multiscale structure of the 8-fold symmetric core scaffold. To date, we have analyzed NPCs
from growing cells engaged in transport, whose plug-like feature in the central channel is comprised of
cylindrically-arrayed FG repeats and cargo complexes. However, the dynamic core scaffold contracts to a
ground state configuration during solubilization of the NE and purification, due to the loss of lateral
membrane tension. To extend our previous studies, a one-step NPC purification has been refined to
minimize aggregation and stabilize membrane protein anchors. We will use stationary cells to provide a
more uniform NPC population for structure determination that will focus on the core scaffold, Nup connector
networks and features of the central channel. In this analysis, we will leverage our experience and
knowledge to visualize NPC components at higher resolution and determine structures with improved
precision, due to the incorporation of refined Nup crystal structures and Alphafold2 computed structure
models. We will also determine single particle structures of relevant Nup complexes that form the
cytoplasmic RNA export platform and which stabilize the NPC within the pore membrane, including
membrane anchors and Nup84 Y-complexes. This will provide additional data to create a more complete
model of the ground state NPC. To probe dynamic features of the NPC, a biochemical treatment that
enhances permeability will be used to alter the conformation of this mega-channel for structural studies.
Collectively, our studies will provide further insights into the roles of Nups in core scaffold assembly, pore
membrane anchoring and nucleocytoplasmic transport, while a comparison with NPC models from humans
and frogs will clarify steps in the molecular evolution of this remarkable channel.

Public health relevance
Rationale: Nuclear pore complexes mediate the bi-directional transport of macromolecules between the cytoplasm and nucleus. Aberrant function of these channels is a causative factor in the etiology of human disease and nuclear transport is usurped in many viral infections and cancers. Structural studies of the yeast NPC will provide a benchmark for understanding the function and evolution of these remarkable eukaryotic channels.